UniProt building community metrics for FAIR and TRUSTworthy resources

PROJECT SUMMARY
UNIPROT BUILDING COMMUNITY METRICS FOR FAIR AND TRUSTWORTHY RESOURCES-
SUPPLEMENT REQUEST 2022
The mission of the Universal Protein Resource(UniProt) is to support biomedical research by
providing a freely available, stable, comprehensive, richly and accurately annotated sequence
knowledgebase. The overall goal of this Supplement application for the UniProt parent grant
(U24HG007822) is to (i) support UniProt to assess and increase alignment with FAIR and TRUST
principles, (ii) to provide a tool to enable data resources to help evaluate their usage, utility, and
impact and (iii) advance the the evaluation of data reuse across data repositories. UniProt has been
a leader in the provision of protein sequence and annotation data since its inception in 2002. As a
large and central piece of the biomedical research infrastructure it has seen a progresive
professionalisation and hardening of its processes and development. This has also happened to
the field as a whole with the creation of sets of principles such as the FAIR and TRUST principles
as well as a growing variety of certifications. UniProt was identified as an exemplar in the original
publication describing the FAIR principles and was also an early adopter of the TRUST principles
gaining CoreTrustSeal certification in May 2020. We will carry out a further self assessment of our
FAIR and TRUST compliance as part of the project leading to a set of goals supporting our
application for renewal of CoreTrustSeal certification in 2023. This work will help to ensure we
remain well aligned with community standards for data and metadata as well as refresh our outlook
for management processes of UniProt. We believe that we are at the forefront of developing
biomedical resources and have developed a range of metrics for understanding the usage, impact
and utility of UniProt. We will develop an interface in GoogleColab to enable the community to view
metrics for UniProt or any other biomedical resource of interest in a rapid way based on publicly
available APIs to literature and patent databases. We are aware that UniProt data is widely reused
across other data resources and this reuse is extremely difficult to measure and can be considered
the greatest gap in our understanding of the impact of biomedical data resources. We will hold a
workshop with key stakeholders to discuss ways to measure reuse across NIH data resources.

Public health relevance
UNIPROT BUILDING COMMUNITY METRICS FOR FAIR AND TRUSTWORTHY RESOURCES- SUPPLEMENT REQUEST 2022 To increase UniProt’s alignment with the FAIR and TRUST principles we will carry out a reassessment against these principles to create a set of actions, leading to a renewal application for CoreTrustSeal certification. To promote best practice in evaluation of data resources usage, utility, and impact we will provide a GoogleColab based tool to generate graphs showing multiple impact metrics developed by UniProt based on open APIs. We will foster discussion across biomedical data resources by holding a workshop to advance the evaluation of data reuse across data repositories.